Lupus Omics Cutaneous Kidney Investigative Team (LOCKIT) - Pain Supplement

Clinical pain phenotypes and mechanisms in rheumatic diseases are poorly understood. The Accelerating
Medicines Partnership Autoimmune and Immune-Mediated Disease (AMP AIM) Program addresses common
themes across autoimmune diseases, and delineating the complexity and impact of pain and the dissociation
between patient and physician perceived disease burden not necessarily related to untreated inflammation is a
major unmet need. Pain phenotypes such as nociceptive (tissue injury), nociplastic (central sensitization), and
neuropathic pain and their contribution to therapeutic non-response constitutes a critical knowledge gap. Pain is
a core domain affecting quality of life from the perspective of patients with Systemic Lupus Erythematosus (SLE),
Psoriatic Spectrum Disorder (PSD), Rheumatoid Arthritis (RA) and Sjögren’s Disease (SjD). This supplement
will utilize skin biopsies acquired by the SLE and PSD disease teams in those with cutaneous disease to identify
novel pain biomarkers. Patients with lupus nephritis and SjD will be included given the importance of pain in
these patients as well and to provide further comparative insights. Governance will be under the leadership of
Jill Buyon (mPI SLE) and Alexis Ogdie (mPI PSD) with collaboration provided by other members of the respective
disease teams and consultation by Yvonne Lee bringing expertise in pain phenotyping. In parallel, efforts will be
harmonized in RA and PSD with a focus on synovial biopsies. Two specific aims are proposed. In Aim 1, pain
phenotypes will be delineated in patients with SLE, PSD, and SjD. In addition to the PROMIS 29 measures,
patients consecutively enrolled will complete the 2016 Fibromyalgia (FM) Survey Criteria and pain
catastrophizing scale. Over 2 years, the SLE team will enroll patients with active skin disease (N=20) and/or new
onset nephritis (N=40), the PSD team will enroll patients with psoriasis and/or PSA (N=30), and patients with
varying clinical and/or laboratory characteristics consistent with SjD (N=20) will be recruited by this third team.
In Aim 2, differences in skin biomarkers and functional brain MRI among patients with SLE, PSD, and SjD with
and without concomitant FM or pain sensitization will be assessed. This aim leverages studies planned to
investigate lesional and non-lesional skin from patients with cutaneous LE and PSD to test the hypothesis that
local nerves play a role in pain sensitization and itch. Following baseline surveys, a subset of patients with skin
biopsies with differing pain phenotypes will undergo functional brain imaging. With systematic collection of deeply
phenotyped patients and extensive omics derived from tissue as a part of AMP AIM, substantial innovations in
pain research are expected.

Public health relevance
Nearly one third of patients with rheumatic diseases are affected by chronic pain, a disabling, life altering condition. This study will leverage the ongoing Accelerating Medicines Partnership Autoimmune and Immune- Mediated (AMP AIM) Disease Program, focusing on patients with Systemic Lupus Erythematosus, Psoriasis and Psoriatic Arthritis and Sjögren’s Syndrome in which molecular mechanisms of underlying disease are being already measured, to better define different types of pain in these individuals and as well evaluate skin biopsies and brain imaging for clues to the mechanisms of pain. This research is expected to stimulate substantial innovations in pain research approaches and methods with the goal of identifying new treatment modalities.